Dynamic association of transcription initiation proteins with chromatin at single-molecule resolution in living yeast

A central paradigm for eukaryotic gene control posits that sequence-specific transcription factors search for and
locate their genomic targets in a crowded nuclear environment, often acting combinatorially and cooperatively at
regulatory DNA elements in chromatin to recruit and direct the ordered assembly of a transcription pre-initiation
complex composed of general transcription factors and RNA polymerase. Although the identities and functions
of several hundred transcription-related proteins are known, there is little information on the timescales under
which they operate in the transcription process, and the regulatory influence of chromatin architecture,
remodeling and modification on transcription protein kinetics. This proposal aims to test the hypothesis that
chromatin binding of transcription initiation proteins in the cell nucleus occurs with rapid kinetics in live cells, and
that chromatin remodeling and modification has a role in regulating transcription protein dynamics. We will use
live-cell single-molecule imaging in the model organism budding yeast to monitor the diffusive behavior of
transcription initiation proteins at high spatio-temporal resolution. This ‘in vivo biochemistry’ approach differs
from and is complementary to ChIP-Seq techniques that map transcription factor occupancy genome-wide at
base pair resolution but provide little information on binding dynamics. To elucidate regulatory contributions of
chromatin architecture to transcription initiation protein dynamics, we will measure their mobilities in yeast
mutants conditionally depleted for chromatin remodeling and modification enzymes.
We will engineer and functionally validate DNA constructs encoding components representative of the
general transcription factors and major sequence-specific DNA binding transcription factors fused to a self-
labeling protein tag (HaloTag) that allows labeling with a cell-permeable organic fluorophore (Janelia Fluor). Live-
cell imaging of fluorescently labeled transcription factors at single-molecule resolution will measure protein
diffusion and distinguish between chromatin-bound and chromatin-free populations and estimate residence
times of the bound population. Further, we will use conditional depletion of 6 major chromatin remodelers and
histone modifiers to reveal changes in the diffusive parameters of transcription initiation proteins under conditions
of chromatin perturbation to inform which among several diffusive parameters are subject to chromatin controls.
By combining with conditional mutant genetics with live-cell single-molecule imaging, we hope to transform
understanding of the kinetic mechanisms by which chromatin architecture regulates the transcription initiation
process and develop a potentially routine technology complementary to current genome-wide analytical
techniques to benefit other areas of yeast nuclear and chromosome biology, including studies of DNA replication,
repair, and recombination.

Public health relevance
Transcriptional control occurs through the actions of hundreds of proteins in the cell nucleus whose identities and functions have been elucidated from decades of genetic and biochemical studies. However, little is known about the timescales under which transcription-related proteins search for and target chromosomal sites in living cells, and how such dynamic associations are influenced by modifications of chromosome architecture. This proposal aims to apply super-resolution fluorescence microscopy to address these questions by directly visualizing the mobilities of major transcription proteins at single-molecule resolution, in living cells of the simple model organism, baker’s yeast, under normal and altered chromosome states.